Characterizing the prevalence and nature of facial recognition deficits in non-proliferative diabetic retinopathy

Project summary/abstract
Facial perception and memory are visual abilities that are driven by an interplay between low-level visual and
higher-level cognitive functioning. Deﬁcits in facial perception and memory are associated with diminished quality
of life and a range of social challenges, and it has been suggested that this functional deﬁcit may be an early
marker for the later onset of structural abnormalities in a variety of conditions. One of these conditions—one that
has received scant attention—is diabetic retinopathy. In a recent systematic review, difﬁculty in perceiving faces
was noted as one of the greatest subjective restrictions on visual functioning. Diabetic retinopathy affects approx-
imately one-third of individuals with diabetes world-wide. The vision loss associated with diabetic retinopathy is
preventable, given early identiﬁcation, medical intervention and monitoring, and behavioral interventions. Diabetic
retinopathy can be generally separated into two classes. The ﬁrst is non-proliferative diabetic retinopathy, which
is characterized by micro-aneurysms, intraretinal hemorrhages, venous beading or intra-retinal microvascular ab-
normalities. The second is proliferative diabetic retinopathy, which is characterized by retinal neovascularization.
In cases of macular edema, there is a thickening of the macula which can result in the loss of central vision.
Deﬁcits in face processing have been studied more frequently in two pathologies that affect the macula: age-
related macular degeneration (AMD) and glaucomatous macular damage. Patients with AMD regularly identify
facial processing as tasks with which they experience signiﬁcant difﬁculty. In the literature on AMD, deﬁcits in
facial processing have been identiﬁed as signiﬁcant components of quality of life. The magnitude of the deﬁcits
in facial processing in AMD are such that they are second only to deﬁcits in reading in subjective complaints.
Finally, it has been noted that deﬁcits in facial processsing are among the ﬁrst subjectively-reported symptoms
of AMD, often occurring before the detection of structural abnormalities. With respect to deﬁcits in facial percep-
tion and memory in glaucomatous macular damage, there is evidence that signiﬁcant impairments exist despite
patients having good central visual acuity. In addition, the amount of the diffuse macular damage is signiﬁcantly
related to impairments in contrast sensitivity and measures of facial recognition and identiﬁcation. It has been
suggested that other related visual pathologies—including diabetic retinopathy—should show similar patterns of
performance deﬁcits. However, very little work on this issue has been done in the case of diabetic retinopa-
thy. The work proposed here represents an important ﬁrst step in addressing this need. The accomplishment
of this work will result in the ﬁrst quantiﬁcation of the prevalence and severity of deﬁcits in facial processing in
diabetic retinopathy, the ﬁrst analytic empirical treatment of the pathology-related differences in processing feat-
ural and conﬁgural information, and the ﬁrst theoretical treatment of those differences. The novel application of
two meta-theories using a new experimental design, along with a modeling approach capable of relating those
meta-theories has the potential to be transformative in this domain.

Public health relevance
Narrative A number of lines of evidence, including subjective self-report, suggest that difﬁculties with facial perception and memory are components of the deﬁcits experienced in diabetic retinopathy. However, very little work has been done on this question. The goals of the present effort are to (a) quantify the prevalence and severity of problems with facial perception and memory in non-proliferative diabetic retinopathy, (b) empirically analyze the representation and processing of two canonical forms of facial information (featural and conﬁgural), and (c) provide a ﬁrst formal theoretical account of that representation and processing, all in a sample of individuals with non-proliferative diabetic retinopathy, with and without macular edema.